A Functional Genomics Approach to Uncover the Mechanisms of Neutrophil Galvanotaxis.

Project Summary/Abstract
During acute inflammation our immune cells orchestrate a complex, but coordinated mitigation response.
Immune cells are especially good at navigating the complex extracellular environment through dynamic
modulation of their actomyosin cytoskeletons, enabling a rapid and effective response throughout the body. The
ability of cells to sense a variety of chemical and physical cues that direct their migratory paths is paramount to
this action. Migration in response to bioelectric currents has long been demonstrated, leading to clinical
applications in wound healing through exogenously applied electric potentials. While also implicated in our
response to infections and in the metastatic spread of some cancers, our understanding of this directional cue,
referred to as galvanotaxis or electrotaxis, remains limited. The experiments proposed in this application will
develop the technology to perform large-scale assays of galvanotaxis and enable a comprehensive genome-
wide strategy to identify the genes and cellular mechanisms involved in human neutrophil galvanotaxis.
In Aim 1, I will fabricate a device that enables electric field-directed separation of the millions of cells required to
perform genome-scale perturbation assays. In collaboration with Dr. Thomas Daniel, I will optimize the device
and assay conditions to develop a robust protocol for studying galvanotaxis. Here I will gain training in
computational and engineering tools for assay development. In Aim 2, I will apply a genome-wide CRISPRi
knockdown screen of galvanotaxis, providing the first comprehensive strategy to identify the key genes involved
in this mode of migration. Due to the technical challenges of such assays, several rounds of experiments will be
performed to increase our confidence in identified gene candidates. In Aim 3, I will use computational and
experimental approaches to gain new insights into the cellular mechanisms of galvanotaxis based on hypotheses
generated from the screen work. In the course of this work, I will collaborate with experimentalist Dr. Sean Collins
who is an expert in receptor-based signaling and signal transduction. He will provide invaluable guidance in
these core components common to most modes of directed cell migration. Throughout Aim 2 and 3, I will also
strengthen my experimental training in molecular biology and biochemical techniques through the expertise of
the Theriot lab.
Importantly, along with these research opportunities, the development award will provide me with additional
career training that I currently need to start and manage a lab. It will also provide critical career training in
laboratory leadership, teaching, grant writing and scientific communication. My mentor, Dr. Julie Theriot, will
provide mentoring that will enable me to successfully transition to independence. This award will therefore
provide the crucial training that will enable my longer-term goals of comprehensively understanding neutrophil
motility and downstream effector functions.

Public health relevance
Project Narrative The ability of cells to sense and migrate in response to electric fields is important during development and has been utilized in the clinic to enhance the healing of wounds. This migratory response is also implicated during infection and in the metastatic spread of cancer cells, but its molecular basis remains poorly understood. In this proposal, I aim to take a comprehensive genome-wide approach to uncover the cellular mechanisms associated with this type of migratory response in immune cells.